Leadership, Planning and Evaluation (LP&E)

LEADERSHIP, PLANNING AND EVALUATION
ABSTRACT
The UCLA Jonsson Comprehensive Cancer Center (JCCC) mission is to accelerate discoveries to prevent and cure cancer. JCCC Director Michael Teitell, MD, PhD (CMINT) led development of an ambitious 2019 – 2023 Strategic Plan that is ~83% complete, exceeding expectations, and a visionary 2024 – 2028 Strategic Plan that builds on progress with broad input from JCCC members and community, institutional, and affiliate leaders, and guidance from three advisory boards. Teitell has the necessary authorities and resources to lead the Center in all mission areas that span cancer research, education and training, community outreach and in-reach, and cancer clinical care in partnership with UCLA Health. He leads a ten member total CCSG Senior Leadership team that meets monthly or more to prioritize resources and activities for cancers with the greatest burden in the Los Angeles County (LAC) catchment area (e.g., breast, lung, prostate, and colorectal), as well as those that disproportionately affect specific populations (e.g., gastric and liver), using prospective planning, continuous improvement initiatives, and data-informed evaluations. An External Advisory Board (EAB), Community Advisory Committee (CAC), and Internal Advisory Board (IAB), provide feedback and share ideas, priorities, and perspectives that guide Center and community beneficial decision making and resource allocations for ongoing and opportunistic activities such as annual symposia, program meetings, topic-specific mini-retreats, workgroups, and new Center initiatives. JCCC governance is tiered with strategy and oversight committees, subcommittees, and workgroups for efficient development, implementation, and assessments of Plan strategy and tactic progress in all mission areas. Top-level, Cancer Center strategic leadership committees include a Vice Chancellor’s Cancer Steering Committee for institutional direction and cancer enterprise resourcing, a Cancer Research Council overseeing CCSG components and JCCC operations, and an Executive Cancer Committee leading cancer clinical program strategy for UCLA Health. Working with and reporting into these leadership committees are topic-specific, operational subcommittees and workgroups that implement initiatives and provide data and updates on progress. There are four Specific Aims for Center Leadership, Planning and Evaluation. Aim 1 is to plan, set, and implement infrastructure, community, and scientific aims of the 2024 – 2028 JCCC Strategic Plan. Aim 2 is to operate a collaborative leadership team of subject matter experts to guide Center progress. Aim 3 is to measure and evaluate mission progress with EAB, CAC, and IAB experts and the JCCC research community, with mechanisms for course correction, when needed. Aim 4 is to prioritize and efficiently allocate Center resources for LAC-guided, impactful JCCC research. Reliable JCCC Senior Leader tools are many, including staffing personnel, financial resources, and assignable space, to advance beneficial Center and LAC catchment area priorities.